Membrane-cytoskeleton interactions in megakaryocytes and platelets

PROJECT ABSTRACT
Abnormal platelet production and function, due to genetic factors, cancer therapy, or unknown causes, pose
significant clinical risks, including bleeding and thrombotic events. Platelets are produced primarily in the bone
marrow by megakaryocytes through intricate processes involving polyploidization and extensive membrane and
cytoskeletal rearrangements. These include the formation of the demarcation membrane system (DMS), the
surface-connected membrane reservoir necessary for proplatelet extension and release within bone marrow
sinusoids. Megakaryocytes also form podosomes, which serve as mechanosensing structures to identify the
most conducive sites for initiating trans-endothelial proplatelet extension. The precise molecular mechanisms
responsible for these unique membrane and cytoskeletal rearrangements remain poorly understood. The
membrane-shaping F-BAR protein PACSIN2 stands central in the interplay between membranes and the
cytoskeleton. PACSIN2 contains an N-terminal F-BAR domain tubulating membranes and a C-terminal SH3
domain interacting with the endocytic GTPase dynamin 2 (DNM2) and actin-nucleation-promoting factor WASp.
Through its F-BAR domain, PACSIN2 also interacts with the cytoskeletal and scaffolding protein filamin A (FlnA),
a critical regulator of platelet production and function. Single nucleotide polymorphisms in PACSIN2 have been
associated with key platelet parameters in humans. Our recent data have discovered pivotal insights into the
role of PACSIN2 in megakaryocyte and platelet biology. PACSIN2 is an internal component of the initiating DMS
in megakaryocytes, where its membrane tubulation activity is regulated by FlnA (PMCID: PMC4492198).
Pacsin2–/– mice display a mild thrombocytopenia with slightly enlarged platelets and marked platelet-intrinsic
thrombus formation defects (PMCID: PMC10841284). Pacsin2–/– megakaryocytes have a mildly defective DMS,
reduced ploidy, and impaired podosome and proplatelet formation. Pacsin2–/– platelets display elevated integrin
β1 activity. Deletion of integrin β1 within megakaryocytes effectively normalizes the thrombocytopenia and
thrombus formation defects. We hypothesize that PACSIN2 regulates membrane-cytoskeletal interactions and
integrin β1 activity to govern the formation and organization of the DMS and podosomes during megakaryocyte
maturation. We propose three aims to investigate the molecular mechanisms underlying how PACSIN2
modulates platelet production and function. In Aim 1, we will characterize megakaryocyte maturation and platelet
production in the presence or absence of PACSIN2 and integrin β1. In Aim 2, we will identify the PACSIN2
effector proteins modulating actin assembly/remodeling at sites of podosome formation in megakaryocytes by
proteomics and overexpression methodologies. In Aim 3, we will define the mechanisms by which PACSIN2
modulates integrin β1 activity to regulate thrombus formation and platelet hemostatic function. We anticipate that
our studies will yield basic information on how PACSIN2 contributes to megakaryocyte and platelet biology.

Public health relevance
PROJECT NARRATIVE Genomic studies have linked single nucleotide variants in the membrane-shaping protein PACSIN2 to variations in platelet parameters. PACSIN2 plays a crucial role in the interaction between membranes and the cytoskeleton. The proposed research aims to deepen our understanding of the molecular mechanisms by which PACSIN2 regulates platelet production and function, and thrombus formation.